Paneth cells-derived IL-17A and liver ischemia reperfusion injury

Liver ischemia and reperfusion (IR) injury is a clinically significant problem during and after liver
transplantation, hepatic resection and portal vein reconstruction surgery. Unfortunately, there is no therapy to
prevent or treat hepatic IR injury. Furthermore, it is becoming increasingly clear that liver IR injury frequently
results in significant extra-hepatic remote organ injury including kidney, intestinal and lung injury as well as a
systemic inflammatory response syndrome and sepsis. In particular, the incidence of acute kidney injury after
liver resection is extremely high and approaches ~50-80% after major hepatic resection or liver transplantation.
Our previous studies implicate small intestinal crypt Paneth cells as the initiator of extra-hepatic remote organ
injury after liver IR in mice. Furthermore, small intestinal Paneth cells are the predominant source of pro-
inflammatory cytokine IL-17A required for generating hepatic and extra-hepatic injury in mice. However, for
clinical translation of these studies leading to therapy, it is critical that we determine whether Paneth cell
dysregulation and degranulation as well as Paneth cell release of IL-17A also occur after hepatic IR in human
and nonhuman primate liver IR injury models. In this proposal, we will elucidate whether small intestinal
Paneth cells dysregulate and release pro-inflammatory IL-17A after human and nonhuman primate liver IR
injury and whether IL-17A neutralization attenuates liver injury as well as extra-hepatic organ injury after
nonhuman primate IR. Exciting preliminary data suggest that cynomolgus monkey liver IR causes profound
Paneth cell degranulation and Paneth cell IL-17A induction coupled with rapid kidney and small intestine injury.
Furthermore, our preliminary data suggest that cynomolgus monkeys treated with IL-17A neutralizing antibody
had markedly less hepatic IR injury as well as reduced post-operative AKI. Preliminary data also suggest that
human small intestine Paneth cells degranulate after ischemic injury. Based on these preliminary findings, we
hypothesize that hepatic IR injury leads to intestinal Paneth cell dysregulation/degranulation and Paneth cell-
derived IL-17A induction leading to intestinal inflammation and apoptosis, subsequent exacerbation of hepatic
injury and induction of acute kidney injury. We also hypothesize that IL-17A neutralization will attenuate
hepatic, intestinal and kidney injury after liver IR in nonhuman primates. We will utilize both in vivo (highly
translational cynomolgus monkey liver IR and human liver transplant studies) and in vitro (freshly isolated
cynomolgus monkey and human Paneth cells) models to further elucidate the mechanisms and potential
therapy for intestinal and renal injury after hepatic IR by testing the following three specific aims.
Aim #1: To demonstrate remote organ injury and Paneth cell degranulation after liver IR injury.
Aim #2: To demonstrate Paneth cell-mediated IL-17A release after liver IR injury.
Aim #3: To develop therapies to reduce non-human primate liver IR injury induced hepatic and extra-hepatic
organ injury.

Public health relevance
Major liver surgery is a very common procedure and liver ischemia and reperfusion injury is a major clinical problem. Many patients suffer complications from liver surgery including acute kidney injury, intestinal barrier disfunction and systemic inflammatory response syndrome leading to sepsis. In this translational proposal, we will determine whether 1) cynomolgus monkey and human liver IR injury cause small intestinal Paneth cells to dysregulate and release IL-17A and 2) IL-17A neutralizing antibody attenuates hepatic as well as acute kidney injury after liver IR in cynomolgus monkeys.